Epigenetic gene regulation for stem cell fates

ABSTRACT
In stem cells, the interactions among transcription circuitry, extrinsic and intrinsic signaling pathways, and
epigenetic modifiers lead to transcriptional outputs that direct different cell fates. These cell fates include self-
renewal, cell differentiation, and cell death. These remarkable properties are fundamental to the biology of
stem cells and essential for human development, yet our grasp of their workings is relatively scarce. This
knowledge deficiency has stark consequences, as the vast majority of human embryos do not complete
development. My lab seeks to uncover the epigenetic mechanisms that underlie stem cell fates during
embryogenesis. We focus on the key knowledge gap: how histone H3 lysine 27 (H3K2)7 modifiers respond to
intrinsic and external cues to dynamically change H3K27 marks, regulate gene expression, and control cell
fates. The H3K27 residue and its modifiers are strongly associated with myriad pediatric and adult cancers and
developmental disorders. PRC2 and UTX catalyze H3K27 methylation and demethylation, respectively, often
to regulate the same chromatin targets. Although PRC2 and UTX are nearly ubiquitous in all cells, their
dysregulation causes cell type- and developmental stage-specific defects. Specifically, PRC2 and UTX defects
result in opposite phenotypes in cell and tissue growth and neural specification in experimental models and
human patients. Therefore, we seek to understand the fundamental mechanisms of PRC2 and UTX in
developmental gene regulation and in the long term, translate our knowledge to disease studies. We had
identified UTX, PRC2-binder YBX1, UTX-binder 53BP1, and PRC2-binder SNIP1 as key epigenetic regulators
of stem cell fates. In research direction 1, we will examine developmental signaling pathways and structural
basis that regulate these protein interactions and stem cell fates. As PRC2 is causally associated with pediatric
high-grade glioma, we will test UTX and YBX1 for epigenetic dependencies in models of this disease. In
research direction 2, we will examine the UTX–53BP1 mechanism at promoters and enhancers and the
coordination of PRC2 and UTX–53BP1 activities by the kinase ATM in pluripotent stem cell models. We expect
to uncover mechanistic basis of the opposing yet cooperative actions of PRC2 and UTX networks in
developmental gene regulation and advance our knowledge about cross-functional factors in transcription and
DNA damage response. The extensive research program we propose is based on our established expertise
and broad vision. Development and execution of these research directions have continuously benefited from
enhancement of diverse perspectives. We expect our results to synergize with each other to reveal epigenetic
programs, signaling pathways, and transcription factors that coordinate fundamental stem cell decisions. Our
findings will have key implications for human disease, tissue homeostasis, and injury repair.

Public health relevance
PROJECT NARRATIVE We are studying a key epigenetic mechanism controlling cell fates in stem cells. Components of this mechanism are associated with pediatric cancers and developmental disorders, suggesting its crucial function in human development. Our success will provide important insights on epigenetic regulation of human embryogenesis and may advance our understanding of disease mechanisms.